The control of gene expression by eukaryotic ribonucleases

Project Summary/Abstract
RNA processing and degradation mechanisms play critical functions in the control of gene
expression. Not only do they regulate global transcripts abundance, but they also provide
quality control mechanisms to eliminate improperly processed or mis-localized transcripts.
Work in our laboratory focuses on two main aspects of RNA-based regulatory processes.
The first axis of research is focused on the function of nuclear ribonucleases and of nuclear
RNA degradation pathways. Nuclear RNA processing and degradation by the RNA
exosome, RNase III and the Rex exonucleases play important roles in ribosome
biogenesis and in controlling expression of genes in response to stress. Work presented
in this proposal will focus on determining the function of nuclear ribonucleases on
regulating the expression of key chromatin remodeling factors during stress and on
identifying the role of the cancer-linked ribonuclease Rexo4 in mammalian ribosomal RNA
processing. The second area of focus of our group is to understand the impact of splicing
inactivation on global gene expression. We have analyzed the function of splicing factors
in vivo using RNA sequencing and shown that splicing inactivation results in the
accumulation of hybrid mRNA-snoRNA (hmsnoRNAs) species which accumulate in the
cytoplasm. We will continue these studies by investigating the function of several
conserved splicing factors in global gene expression and by analyzing the global impact
of splicing inactivation on the proteome, including the translation of hmsnoRNAs. Overall,
the proposed studies are expected to have a high impact on our understanding of the
mechanisms by which post-transcriptional processes globally regulate gene expression.

Public health relevance
Defective RNA processing is frequently associated with genetic diseases as evidenced by mutations in RNA exosome subunits resulting in Pontocerebellar Hypoplasia. Several of the proteins studied in this proposal such as Rexo4 or Bromodomain proteins are also associated with cancer. Our studies of the control of gene expression by the RNA exosome and Rexo4, and of the regulation of the expression of bromodomain factors will shed light on the molecular mechanisms involved in diseases affecting RNA metabolism.